Administrative Supplement Preclinical markers of Alzheimer's disease using psycholinguistic semantic measures

PROJECT ABSTRACT
The clinical diagnosis of Alzheimer’s disease (AD) is based on the core criterion of memory impairment, but
biomarker-detectable pathophysiological changes start decades before clinical symptoms. This preclinical
phase, in which someone has the neuropathology of AD but does not yet show clinical symptoms, is crucial for
potential intervention and timely diagnosis for patient and caregiver. The preclinical phase is currently only
detectable with expensive or invasive biomarkers. Because current cognitive measures are not sensitive to the
preclinical phase of AD and have low specificity and large variation with regard to individuals’ educational and
cultural exposure, there is a critical need to develop sensitive, low-cost, and high-access cognitive markers for
early detection in diverse older adults. The primary goal of this project is to investigate if novel psycholinguistic
metrics of existing cognitive test data can accurately identify people in the earliest stages of AD. The semantic
fluency task—naming as many animals in one minute—tests semantic memory, one of the first cognitive domains
to become impaired in AD. Traditionally, semantic fluency is scored by the total number of items. However, there
is a wealth of information at the item-level of this task, because words are organized in a semantic network that
becomes vulnerable during AD, specifically for words that are poorly connected and not often used. These traits
of words in the semantic network can be captured with novel psycholinguistic metrics, such as lexical frequency,
e.g., ‘dog’ is a high-frequent word in our language, as opposed to ‘iguana.’ The K99 phase of this study showed
that novel psycholinguistic item-level metrics related to memory decline over time over and above other
traditional neuropsychological scores, related to brain volume over and above established genetic, subjective,
and cognitive risk factors, and related to more cortical thinning across eights years in high-risk individuals without
a dementia diagnosis. In the R00 phase, psycholinguistic metrics will be used to estimate the temporality of
semantic impairment across the AD continuum (Aim 1) and determine the sensitivity and specificity of
psycholinguistic measures to predict progression to clinical AD (Aim 2). Since the relationship of demographics
to psycholinguistic metrics is not well understood, this project strives to deconstruct cultural and demographic
effects on these metrics in order to maximize their potential utility in early diagnosis among diverse older adults.
For the R00 aims, the project will employ advanced statistical analyses to investigate data from two large
longitudinal cohorts with participants from a range of socio-demographic backgrounds and semantic fluency data
in English and Spanish. The R00 proposal lays the foundation for an independent research program focused on
semantic processing in normal aging and across the AD continuum. The results of the proposed research have
the potential to translate into a clinical tool that we can use across educationally, linguistically, and culturally
diverse individuals to refine who to select for intervention trials.

Public health relevance
PROJECT NARRATIVE The number of individuals with clinical Alzheimer’s disease (AD) is rapidly increasing worldwide due to aging of the population, but current cognitive measures lack sufficient sensitivity and specificity to detect subtle decline within the preclinical phase. There is a critical need for tools that are sensitive to AD neuropathology during the preclinical phase that are low-cost, high-access, and fast to administer that can be used across educationally, linguistically, and culturally diverse older individuals. The goal of this project is to identify metrics for semantic impairment in diverse individuals that correlate with AD neuropathology and predict clinical decline.